The Hawaii Minority/Underserved NCORP

The overall goal of the Hawaiʻi Minority/Underserved NCORP is to provide access and
facilitate enrollment of Hawaii’s diverse, multiethnic population to NCI sponsored trials.
Thus we will enhance accrual of underrepresented populations including Native
Hawaiians, other Pacific Islanders, Asian-Americans (Chinese, Japanese, Filipino and
Korean), adolescents and young adults (AYA), the elderly and sexual and gender
minorities (LGBTQ). Our NCORP is the primary provider of NCI clinical trials and cancer
care delivery research (CCDR) in the State of Hawaiʻi where nearly 75% of the population
is comprised of multiple minority racial/ethnic groups. The Hawaiʻi M/U NCORP supports
an integrated network of affiliates and sub-affiliates with the extensive menu of cancer
studies, research infrastructure and data management. Our NCORP has successfully
extended CCDR studies from the originally designated sites to other hospital affiliate sites
with plans to further extend them to physician office sites. We solicit community input from
Native Hawaiian and LGBTQ advocates to review the suitability of trials as well as to
address their healthcare needs. Non medical oncology community investigators and staff
have leadership responsibility in imaging, prevention and CCDR studies. Our NCORP
leaders have extensive experience in cancer clinical trials, health care delivery and
disparities. They have served on multiple NCI committees. Participation in NCI’s
personalized medicine, cancer control, prevention, treatment and CCDR research will
further reduce cancer health care disparities and the cancer burden for the people of
Hawaiʻi and beyond.

Public health relevance
The Hawaiʻi Minority/Underserved NCORP aims to: 1) conduct cancer clinical trials and cancer care delivery research, 2) continue contributing to NCORP research bases and NCI priorities, and 3) enhance participation of Hawaii‘s diverse multiethnic and at risk population in NCI sponsored trials in order to reduce health care disparities and the burden of cancer for the people of Hawai‘i and elsewhere. !